A Type I Hybrid Effectiveness-Implementation Trial of "Mothering from the Inside Out" (MIO)

Project Summary/Abstract
Mothers with substance use disorders (SUDs) face unique challenges with respect to the intersection of
parenting and recovery. For this reason, they rarely benefit from evidence-based parenting interventions that
have been brought to scale with the general public or child behavioral problems in mind. A different approach
is needed. Mothering from the Inside Out (MIO) is the first attachment-based parenting intervention for mothers
with SUDs that targets parental reflective functioning (RF). Parental RF is the capacity to (a) identify and
regulate emotions that are activated during stressful parenting situations and (b) accurately recognize and
understand young children’s need for stability, security, and sensitivity in the mother-child relationship. MIO
has been shown to have bigenerational benefit by improving parental RF, maternal caregiving, and children’s
attachment security while also reducing maternal psychiatric distress and relapse to substance use when
delivered by researchers in randomized clinical trials with mothers enrolled in outpatient substance use
treatment. However, in the third community-based efficacy trial when delivered by SUD treatment counselors,
MIO was not associated with the same magnitude of improvement in RF or caregiving behaviors, raising
important questions about the science-to-service gap. There remains a critical need to understand the
implementation factors that may be related to enhanced treatment outcomes for MIO when delivered under
‘real-world’ conditions. Therefore, we propose to test MIO’s effectiveness when delivered in four substance use
treatment programs where responsibility for MIO training and delivery will be assumed by community-based
treatment providers. We also propose to conduct an implementation evaluation to examine key implementation
constructs when integrated in four outpatient SUD treatment clinics. In this Type I hybrid effectiveness-
implementation study, we will (a) conduct a randomized effectiveness trial where 200 mothers will be
randomized to receive MIO plus standard outpatient SUD services versus standard outpatient SUD services
alone; (b) replicate testing of the MIO mechanism of change with a larger cohort of counselors and clients; and
(c) assess the impact of key implementation constructs on real-world delivery of MIO. Data collected in the
effectiveness trial and the implementation evaluation will allow us to test causal effects and mechanisms of
change within MIO under natural conditions while also gaining greater understanding of the implementation
process to guide future large-scale implementation and dissemination projects. MIO has demonstrated the
potential to interrupt a pernicious cycle involving the disruption of early attachment relationships that
represents risk for the health of both mother and child. This Type I hybrid effectiveness-implementation study
will accelerate our progress in bringing MIO to scale while ensuring continued methodological rigor aimed at
optimizing treatment outcomes under real-world conditions.

Public health relevance
PROJECT NARRATIVE Mothers with substance use disorders face unprecedented stress in their roles as parents working to care for their children while maintaining healthy recovery. Mothering from the Inside Out (MIO) is the first attachment- based parenting intervention designed specifically for mothers in recovery from substance use disorders that has been shown to have bigenerational benefit in multiple randomized controlled trials. This project will: (a) test the effectiveness of MIO among women in outpatient addiction treatment under ‘real-world’ conditions, (b) further elucidate the MIO mechanism of change associated with improvements in caregiver behavior and maternal mental health outcomes, and (c) assess key implementation constructs to support optimal uptake and treatment in future dissemination studies; closing an important science-to-service gap for an underserved population in an effort to support maternal and child health simultaneously.